BIOLOGICAL STUDIES WITH LIVER PEROXISOME PROLIFERATORS

The purpose is to pursue investigations to delineate the acute and long-term effects of hypolipidemic hepatic peroxisome proliferators, in an attempt to understand the biologic significance of peroxisomes in general and peroxisome proliferation in particular. We will expend considerable effort toward evaluating biologic events associated with hepatic peroxisome proliferation. These studies will include: screening of selected chemicals of unusual structure with potent hypolipidemic activity for induction of peroxisome proliferation and peroxisome-associated enzymes in hepatic and extrahepatic cells, characterization of peroxisome membrane by freeze-fracturing, purification and subcellular localization of 80,000 MW protein induced in liver by hepatic perosisome proliferators, and induction and degradation of peroxisomes and peroxisome-associated enzymes in vitro in isolated liver cells. In addition, the proposed research will also strive to establish, as well as elucidate, the role, if any of persistent peroxisome proliferation and hepatomegaly induced by the hepatic peroxisome proliferators in the initiation and promotion of hepatocellular carcinomas in rats. The information obtained from these studies should further our knowledge of peroxisomes as well as allow us to recognize the implications of the multiplicity of biologic effects of peroxisome proliferators.